Rapid point of care Hepatitis C virus detection using a long-lasting luminescent cascade signal amplification

PROJECT SUMMARY
Hepatitis C virus (HCV) infection poses a formidable global health challenge, impacting an estimated 58 million
individuals worldwide, with 1.5 million new infections emerging annually. If left untreated, HCV can progress to
severe conditions such as cirrhosis and hepatocellular carcinoma. Despite recent strides in cost-effective HCV
treatments, swift and early detection of active cases remains a key hurdle, especially in resource-limited
settings. Alarmingly, only 21% of HCV-infected individuals receive a diagnosis globally, underscoring the
urgent need for improved screening strategies.
Of particular concern are American Indians and Alaska Natives (AI/AN), who bear a disproportionate burden of
HCV infection. They experience a rate of 2.9 cases per 100,000, compared to 0.5 cases per 100,000 in African
Americans and 1.2 cases per 100,000 in non-Hispanic Whites, with higher mortality rates. Achieving the World
Health Organization's (WHO) HCV elimination targets, aiming for an 80% reduction in new infections and a
65% reduction in HCV-related mortality by 2030, requires substantial improvements in screening efforts. The
existing two-step HCV testing protocol, involving initial antibody testing followed by confirmatory RNA testing,
proves costly and time-consuming, leading to attrition in HCV management.
An alternative approach lies in cost-effective, rapid, sensitive, and specific Point-of-Care (POC) HCV antigen
(Ag) testing, offering potential for streamlined screening and diagnosis in a single step. However, commercially
available and FDA-approved devices for POC HCV antigen testing are currently lacking. Existing assays are
laboratory-based, relatively costly, and lack the necessary sensitivity and specificity, particularly for samples
with low viral loads (<1000 IU/mL).
To bridge this gap, there is an imperative for the expeditious development of an affordable, rapid, sensitive,
and specific POC HCV Ag diagnostic assay. Here, we propose to develop POC LUCAS (LUminescence
CAscade-based Sensor), an ultrasensitive bioluminescence assay designed for HCV Ag detection using a
fingerprick volume of whole blood. POC LUCAS HCV Ag aims for complete automation, delivering rapid results
in under 30 minutes with high sensitivity (Limit of Detection ranging from 200 IU/mL to 1000 IU/mL). This
system utilizes a minimal fingerprick volume (<100 µL) of whole blood, applied to an affordable (material cost
<$2), disposable, and easily mass-producible microfluidic-based cartridge.
In summary, POC LUCAS HCV Ag assay stands as a promising solution to enhance access to HCV care,
especially for populations disproportionately affected, providing a comprehensive and accessible approach to
diagnosis in resource-limited settings and populations experiencing HCV-related health disparities.

Public health relevance
PROJECT NARRATIVE The global challenge of Hepatitis C virus (HCV) infection affects millions annually, with 58 million individuals suffering from chronic HCV and 1.5 million new infections emerging each year. Despite progress in HCV treatments, early detection remains a hurdle, particularly in resource-limited settings and those disproportionately affected with HCV infection such as the American Indians and Alaska Natives (AI/AN), where only 21% of infected individuals receive a diagnosis. We aim to address the unmet clinical need by developing LUCAS HCV Ag (LUminescence CAscade-based Sensor), a rapid, sensitive, and automated point- of-care assay that provides results within 30 minutes using fingerprick volume whole blood, offering an affordable and easily mass-producible solution to enhance access to HCV care, especially for disproportionately affected populations particularly AIs/ANs.